NUTRITIONAL INTERVENTION ON DISEASE AND GROWTH IN CROHN'S DISEASE

This study concerns the effects of early sustained nutritional support on growth, body composition, sexual maturation and disease activity in patients with Crohn's Disease.